EFFICACY AND SAFETY OF TIBOLONE IN POSTMENOPAUSAL WOMEN

To determine the minimum effective dose of Tibolone for prevention of menopausal osteoporosis and to demonstrate the efficacy, safety and acceptability of the medication at the therapeutic dose for this indication.